Vet-LIRN Network Capacity-Building Projects

Project Summary / Abstract
The current capabilities of the Bacteriology (BACT) section in antibiotic sensitivity testing (AST) rely on
equipment that provides inconsistent reporting and often requires us to fall back to methods that only
give qualitative results. Both of which make it impossible to track any trends in susceptibilities. The
Sensititre AST system provides consistent, quantitative results, and when paired with the AIM automated
plate-loader, would increase the efficiency and accuracy of sample processing greatly. The BIOMIC V3
plate reader and data management system would give us AST breakpoints based on the most current
Clinical and Laboratory Standards Institute (CLSI) guidelines and quantifiable data that would allow for
antibiotic resistance tracking. With this new data management capability, we would be able to participate
in the NAHLN Antimicrobial Resistance (AMR) Pilot Program.

Public health relevance
Initial activity will focus on integration of ALPC-VDL personnel, methods, and instrumentation into the established activities of Vet-LIRN programmatic initiatives. The specific goals of this phase of work include assessing surveillance needs from FDA subject matter experts, providing chemical characterization and bacterial isolation and identification with antimicrobial resistance testing to determine how current capabilities meet Vet-LIRN requirements, and evaluating and enhancing readiness of ALPC-VDL personnel systems to meet surges in sample throughput associated with an emergent scenario.